Clonal hematopoiesis, inflammasomes and atherosclerosis

Project Summary
Clonal hematopoiesis (CH) has emerged as an independent risk factor for atherosclerotic
cardiovascular disease (CVD). CH commonly arises from mutations that cause a loss of function
in epigenetic modifiers such as TET2 or that increase hematopoietic cytokine signaling (JAK2VF).
These variants promote hematopoietic stem cell (HSC) expansion, myelopoiesis and
inflammatory responses in myeloid cells. We have shown a novel role of the AIM2 inflammasome
in atherosclerosis promoted by the Jak2VF mutation, and provided evidence for involvement of
AIM2 in increased CVD in humans with JAK2VF and other forms of CH. In contrast, the NLRP3
inflammasome has been implicated in accelerated atherosclerosis in Tet2 CH. The mechanisms
linking inflammasomes to atherosclerosis remain poorly understood and related therapies not well
developed. The overall goal is to explore mechanisms and novel treatments of inflammatory
responses in CH. We will focus on atherosclerosis in Tet2 and Jak2VF CH, which have the
strongest associations with human CVD and feature prominent inflammasome activation, in
mouse models and human cells. We recently developed a mouse model of Jak2VF CH in which
a very small number of mutant cells promotes atherosclerosis. In Aim 1 we will test the hypothesis
that in Jak2VF or Tet2 mutant cells inflammasome activation and secretion of IL-1b seeds Nlrp3
inflammasome activation in bystander wild type macrophages in plaque. This inflammatory
seeding may involve signaling through IKK2 and Jak1/Stat signaling pathways macrophages. In
Aim 2 we propose to investigate anti-atherogenic effects of Jak1 deficiency in hematopoietic and
myeloid cells in Tet2 deficiency, including studies in human iPS-cell derived macrophages.
Inflammasome activation leads to cell death by pyroptosis, leading to plasma membrane rupture
and release of DAMPs. In Aim 3 the impact of a novel inflammasome-activated mediator of
plasma membrane rupture (PMR), Ninjurin-1 (Ninj1) on macrophages subpopulations and
atherosclerosis will be investigated. Proposed studies have the potential to support the precision
targeting of new anti-inflammatory treatment to specific groups of patients with CH.

Public health relevance
Project Narrative Clonal hematopoiesis arises from mutations in blood forming cells that promote inflammation in white blood cells and increase risk of atherosclerotic cardiovascular disease in humans. We propose to investigate the mechanisms underlying atherosclerotic plaque inflammation in clonal hematopoiesis, with a view to the development of new anti-inflammatory treatments that may be targeted to specific groups of patients with clonal hematopoiesis.